Hypertensive Toads: Investigating the Physiological and Evolutionary Pathways to Salt Tolerance in Amphibians

PROJECT SUMMARY
My lab focuses on understanding the evolutionary and physiological mechanisms that enable salt-sensitive
freshwater organisms, such as anuran amphibians, to develop resilience in saline environments. Chronic
exposure to elevated salt levels, whether from environment or diet, can cause detrimental health effects for
frogs and humans alike, as neither are well-equipped to manage excessive internal salt. However, my previous
research has shown that some anuran species have adapted to tolerate elevated salt levels, allowing them to
establish populations in coastal brackish habitats. We leverage the problem-solving power of adaptive
evolution to understand how selection shaped physiological pathways that enhance salinity tolerance while
also investigating how evolution mitigates the long-term costs of chronic salt exposure. This research will
uncover new physiological strategies for coping with elevated salt levels, shed light on the broader risks
associated with long-term salt exposure, and identify alternative mechanisms for reducing the costs of high salt
intake, which may contribute to the development of solutions aimed at reducing the health effects of high-salt
diets in humans. My previous work has identified several physiological and evolutionary mechanisms that likely
contribute to anuran persistence in saline habitats. These discoveries form the foundation of this research,
which will comprehensively test and validate these candidate mechanisms. Specifically, we will pursue two
research directions: 1) investigating the physiological mechanisms of salt tolerance in coastal anurans over
short timescales and 2) assessing the long-term costs of chronic salt exposure and how adapted populations
mitigate these challenges. By comparing coastal and inland populations of two sympatric Hyla (treefrog)
species that exhibit different physiological and adaptive responses to saltwater, we aim to understand how
selection addresses the physiological challenges of salt stress across timescales and across levels of
evolutionary divergence. Our integrative and comparative approach will utilize a suite of experimental and
physiological assays that incorporate genetic, environmental, and temporal variables, to rigorously test key
evolutionary and physiological hypotheses underlying salt tolerance. In addition to expertise in local adaptation
and amphibian osmoregulatory biology, our lab is fully equipped with the necessary tools for the physiological
assays, molecular analyses, and experimental methodologies described herein. These resources enable us to
effectively address key questions across multiple biological levels—from molecular to organismal—ensuring a
comprehensive understanding of salt tolerance. Ultimately, our research will uncover physiological strategies
for managing elevated salt levels, highlight the broader risks of chronic exposure, and identify mechanisms that
mitigate the long-term costs of chronic salt exposure. We expect to uncover new and alternative pathways for
addressing the health challenges posed by chronically high sodium intake in humans and amphibians.

Public health relevance
PROJECT NARRATIVE Although anuran amphibians are highly sensitive to salt stress, some coastal populations have evolved mechanisms to thrive in brackish environments. Understanding how amphibian populations manage acute stress and minimize long-term adverse effects could uncover novel mechanisms and pathways relevant to mitigating the negative health impacts of chronic high-salt diets in humans. This research will explore adaptive variation in salt tolerance across anuran populations and species, focusing on molecular and physiological mechanisms and how adaptation reduces the long-term negative effects of salt stress.